WNPRC Supplemental Request for Nonhuman Primate Enclosures to Equip HIV/AIDS-Related Research Facilities

Project Summary/Abstract
Parent grant (P51 OD011106). The Wisconsin National Primate Research Center (WNPRC) is one of seven
federally funded National Primate Research Centers and the only one in the Midwest. WNPRC's mission is to
increase the understanding of basic primate biology and to improve human health and quality of life through
research. To accomplish this, the WNPRC helps discover treatments, preventions and cures for human disease;
generates new knowledge of primate biology, from the molecular and whole animal levels to the understanding
of primate ecosystems; facilitates research progress by providing expertise, resources and training to scientists
worldwide; and collects primate information and disseminates to the research community and to the public.
Administrative Supplement. The WNPRC supports a large cadre of investigators utilizing the simian
immunodeficiency virus (SIV) and the simian/human immunodeficiency virus (SHIV)-infected rhesus and
cynomolgus macaque as models of human immunodeficiency virus (HIV) infection and acquired
immunodeficiency syndrome (AIDS). In 2019, the WNPRC obtained C06 funding to construct a new infectious
disease suite consisting of seven macaque holding rooms, one procedure room engineered to support a variety
of procedures commonly performed with SIV/SHIV infected macaques, as well as appropriate husbandry support
space. The single, straightforward, specific aim of this P51 administrative supplement proposal is to secure
funding to purchase a substantial portion of state-of-the-art mobile “four-bank” nonhuman primate enclosures
necessary to equip the new infectious disease suite as the COVID-19 pandemic has greatly reduced the financial
reserves the Center planned to utilize to purchase these enclosures.

Public health relevance
Project Narrative The Wisconsin National Primate Research Center (WNPRC) base operating grant supports services and resources for research addressing human health issues utilizing non-human primate models. This proposal for an administrative supplement to the WNPRC base grant (P51 OD011106) requests funding to purchase a portion of the nonhuman primate enclosures needed to equip the new infectious disease suite we are constructing to support HIV/AIDS related studies at the Center.